Lysosome‐Lipid Droplet Interactions in Fatty Acid Metabolism

The interactions between lysosomes and lipid droplets represent the processes of mobilization of lipids
and energy required for cell metabolism and lipid homeostasis. Lipophagy, for lipid degradation, is a
known type of lysosome-lipid droplet interaction. Our preliminary studies and results from others suggest
there is a second type of lysosome-lipid droplet interaction, which mediates lipid transport from
lysosomes to lipid droplets for lipid synthesis and storage. This process is probably mediated by the
organelle membrane contact sites (MCS), which are recently defined as tethered organelles, organized
by protein-protein and protein-lipid interactions. MCS provide vectorial transport of lipids between
heterologous organelles and are increasingly appreciated for their role in lipid homeostasis. Our group
will study lysosome-lipid droplet interactions with a focus of lysosome-lipid droplet MCS in the context of
fatty acid metabolism. Regulation of free fatty acids within the cell is critical for normal cell functions, as
excess cytosolic free fatty acids cause toxic effects to cells and tissues (named lipotoxicity) and thus
have been recognized as a causative factor in many metabolic disorders, including non-alcoholic fatty
liver disease (NAFLD). One source of cytosolic free fatty acids is the lysosome, which releases free fatty
acids after digesting endocytosed extracellular lipids and autophagic intracellular membranes and lipids.
Increasing the transport and storage of free fatty acids into lipid droplets protects cells, including liver
cells, from lipotoxicity. Therefore, lysosome-lipid droplet MCS may play an important role in prevention of
lysosomal free fatty acid-induced lipotoxicity. However, it is not clear whether MCS exist between
lysosomes and lipid droplets and whether lysosome-lipid droplet MCS transport free fatty acids.
Moreover, it is not known whether lysosome-lipid droplet MCS play a role in preventing lysosome-
triggered lipotoxicity and regulating fatty acid metabolism. Our recent studies support the existence of
lysosome-lipid droplet MCS in human liver cells, and we identified the protein-protein interactions at
lysosome-lipid droplet MCS through a genetic screening in yeast. In the next five years, we will define the
principal components and function of lysosome-lipid droplet MCS, and test if promoting MCS formation
will prevent or reduce lipotoxicity and thus NAFLD progression in a mouse model. By investigating the
features, mechanisms, and physiological functions of lysosome-lipid droplet MCS, our work will reveal a
previously undefined interaction between lysosomes and lipid droplets and uncover a novel mechanism
of free fatty acid transport. This mechanism will deepen the understandings to fatty acid metabolism,
lipotoxicity, and the pathology of NAFLD.

Public health relevance
NARRATIVE Non-alcoholic fatty liver disease (NAFLD) is a metabolic disorder with a high prevalence in the USA and is found to be tightly associated with the cellular toxic effects caused by excess input of lipids in the liver. The proposed studies will investigate the knowledge gap of the fate of the cell digestion-derived lipids, and how it relates to NAFLD progression. Identification of the transport and distribution of this part of lipids and the related molecular mechanisms will deepen the understanding to NAFLD pathology and promote strategy designs for NAFLD interventions.